SUD-t Map: A Big Data Digital Platform to Identify and Characterize SUD Treatment Opportunities to Address Health Disparities

1.a. PROJECT SUMMARY/ABSTRACT
The proposed project will address a preeminent public health challenge that is acute and immediate:
developing innovative commercial digital solutions to positively affect fundamental risk factors associated with
health disparities and social determinants of health (SDOH) experienced by communities afflicted with
substance use disorder (SUD). With an alarming 81,000 overdose deaths recorded in the 12 months ending on
May 2020, it is clear that the current national opioid epidemic is being accelerated and worsened by the
ongoing COVID-19 pandemic. As these dual health emergencies collide, communities that are negatively
impacted by health disparities remain disproportionately at higher risk for substance use disorders. At the
same time, ensuring sufficient and equitable access to SUD prevention and treatment services remains a
significant challenge, and few if any tools exist to provide actionable business and public health intelligence
needed by different SUD stakeholders, including government agencies, corporate employers, and technology
companies, about where and what types of prevention and treatment services are needed. In response, this
project will conceptualize, develop and pilot test a multimodal digital tool that will create a comprehensive
nationwide database of SUD treatment facilities, combined with an analytical health disparities data layer that
can enable SUD-related intelligence. The tool will generate actionable insights on where SUD treatment
capacity is insufficient and in turn reduce health disparities related to improving access to SUD treatment
specific to priority minority populations and underserved communities. The project will use technology
approaches in big data, predictive modeling, and custom data visualization and has the following project aims:
Milestone 1: Use advanced methods of data mining to identify and collate a national SUD treatment
facility database that includes specific community and business characteristics of interest;
Milestone 2: Join, integrate, and analyze SUD treatment facility data with existing demographic,
economic, social, and health disparity-related data to enable identification of communities at highest risk of
health-related SUDs including a specific focus on identifying communities with insufficient treatment
access; and
Milestone 3: Build a web-hosted MVP data visualization solution to enable actionable public health and
business intelligence identifying SUD health disparity treatment access risks and target use of the solution
for customer segments including government agencies, corporate employers, and technology companies.
This is a critical opportunity to directly address health disparities related to SUD by developing an innovative
digital tool that can help ensure sufficient access to prevention and treatment services in communities who
have the greatest need.

Public health relevance
1.b. PROJECT NARRATIVE. With a reported 81,000 overdose deaths recorded in the 12 months ending on May 2020, it is clear that the national opioid epidemic has accelerated due to the current COVID-19 pandemic. This places communities already suffering from health disparities and social determinants of health at higher risk for substance use disorder, while prevention and treatment access also experiences significant challenges. In response, the proposed project will leverage advanced methods in big data, machine learning, and data visualization to conceptualize, develop and pilot a multimodal tool that identifies current and future SUD treatment needs and capacity gaps for communities at risk for health disparity related SUDs.